The Regulatory Mechanisms of Osteoclasts

Abstract
Osteoclasts are multinucleated cells primarily responsible for bone resorption. The dysregulation of osteoclast
differentiation can result in excessive bone resorption and is key to the pathophysiology of bone diseases,
such as osteoporosis, rheumatoid arthritis, and lytic bone metastasis. Despite substantial advances in anti-
resorptive therapies, developing therapeutic interventions for pathologic osteoclasts has been challenging due
to the occurrence of rare but significant side effects, drug tolerance, and patient compliance. Our overarching
hypothesis is that these unwanted effects of antiresorptive therapies can be lowered by cell-specific targeting.
Osteoclasts are long-live cells that continuously acquire new nuclei by fusion with circulating osteoclast
precursor cells (cOCPs) and are recycled through the fusion and fission cycle of osteomorphs. This new
concept of long-lived osteoclasts highlights the important role of cOCPs in the management of osteoclasts and
supports that cOCPs can serve as an osteoclast-specific target. We have identified and characterized human
cOCPs and found a positive association between cOCPs and osteoporosis. Sorted cOCPs from the blood
circulation have a higher osteoclastogenic potential than other myeloid cells and effectively differentiate into
osteoclasts. Moreover, cOCPs exhibit distinct morphology and transcriptomic signatures compared to other
myeloid cells. cOCPs are inversely correlated with bone density and are positively associated with serum
CTX1 in postmenopausal women. Intriguingly, we found that nuclei in multinuclear osteoclasts are
heterogeneous, and ‘new vs old nuclei’ show distinct gene expression profiles. We hypothesize that cOCPs
reflect the changes in bone environment and that newly incorporated nuclei from cOCPs regulate osteoclast
activity. In this application, we aim to determine the mechanisms underlying the regulation of cOCPs. Our
specific aims are 1) to elucidate the underlying mechanism by which cOCPs are regulated and 2) to determine
the mechanism governing the function of cOCPs. We anticipate that the proposed study will provide new
insights into the regulatory mechanism of osteoclast formation and enable us to investigate osteoclast-specific
regulation, ultimately leading to improved management of the course of pathological bone loss.

Public health relevance
Project Narrative Osteoclasts are the sole bone-resorbing cells. Dysregulation of osteoclasts results in excessive bone loss. At present, available strategies for the prevention and treatment of bone loss have significant limitations, rendering prolonged use undesirable. A better understanding of osteoclast regulation will offer new opportunities for disease prevention.